Administrative Core

This Core will administer the 3 Projects and 2 other cores on this Program. The Core will be responsible for managing the budget of the various Projects and Cores. It will also organize the bimonthly meetings of program Faculty and related personnel, the biannual symposia on subjects of interest to the Program and the biannual meetings of the External Advisory Board.